RECOMBINANT MIS CANCER THERAPEUTIC PRODUCED IN PLANTS

This project aims to develop a plant-based expression system for cost- effective bioproduction of recombinant human Mullerian Inhibiting Substance (MIS). MIS has significant potential as a therapeutic for cancers of gynecological origin because of its ability to inhibit the in vitro growth of tumor cells originating from these cancers. Medical applications of MIS have been slowed, however, by the inability of available expression systems to produce adequate supplies of MIS protein for clinical testing and delivery to patient populations. CropTech's innovative expression technology promises to overcome this limitation through use of non-proliferating plant tissue to rapidly induce de novo recombinant proteins at extremely high rates followed by efficient isolation and purification. This SBIR Phase I project will attempt to develop this production system for MIS by addressing the following specific objectives: 1) To generate plant expression vectors encoding the human MIS cDNA, 2) To express MIS transiently in tobacco cell cultures, 3) To generate stably transformed tobacco plants expressing MIS at high levels, and 4) To initiate studies on molecular conformation and biological activity of plant-produced MIS. Success in these objectives will support continued research to apply this technology for MIS production and cancer therapy and provide a prototype for bioproduction of other related growth factors with therapeutic potential. PROPOSED COMMERCIAL APPLICATION: The implications of making therapeutically important proteins such as MIS cheaply and easily in plants are far reaching. Clinical and basic studies needed for commercialization but not now possible due to cost or quantity of proteins will be possible. Furthermore, the economic impact of finding alternative, healthy uses for tobacco agriculture business in this country could be enormous.